ONCOGENES OF ADRENAL TUMORS

This study is continuing with collection of tumors and assays for oncogene mutations. The project is open-ended and as new oncogenes are uncovered, additional hypotheses will be tested in the laboratory.